RETROVIR IN PATIENTS INFECTED WITH HIV WHO ARE ASYMPTOMATIC

The purpose of this study is to evaluate the safety, tolerance, and efficacy of chronic administration of retrovir in HIV infected adult patients without clinical manifestations of the disease.